Metabolic Endpoints for Obstructive Sleep Apnea Following Twelfth Cranial Nerve Stimulation (MET12)

ABSTRACT SUMMARY
Candidate's Career Goal. Dr. Nathan Nowalk's goal is to become an independent physician-scientist leading
clinical trials to elucidate the metabolic and cardiovascular effects of obstructive sleep apnea (OSA) and how
current therapies can mitigate risk and improve outcomes. Through the training outlined in this one-year
F32 award, he will gain the skills necessary to perform advanced statistical analyses in metabolism and clinical
trial management, which will be instrumental in him achieving this goal. Problem to be Addressed. OSA is a
highly prevalent sleep disorder and an independent risk factor for cardiometabolic disease. Treatment of OSA is
significantly limited by intolerance to positive airway pressure (PAP). Hypoglossal nerve stimulation (HNS)
therapy is a surgical alternative to PAP that is rapidly being adopted. Dr. Nowalk's proposed study is the first to
examine the metabolic effects of HNS therapy and will have significant impact in the care of patients with OSA.
Candidate Background. Dr. Nowalk is a sleep medicine research fellow at the University of Chicago
(UChicago). He completed Internal Medicine residency (2018) and was selected to serve as chief resident (2019-
2020). He was recruited to UChicago for Pulmonary-Critical Care fellowship (2020), where he has begun to
develop expertise in sleep-disordered breathing with 2 first-author publications, and 6 national conference
presentations. His section has a strong commitment to supporting his academic career, including selecting him
for a T32 grant (2022). He is currently completing a Master of Science in Public Health Sciences. Career
Development Plan. Dr. Nowalk proposes building on his early research experience and master's coursework to
develop expertise in advanced statistical analyses in glucose metabolism and begin to manage and analyze
clinical trials. Additionally, he will broaden his exposure to sleep research methods and the areas requiring further
investigation through a portfolio of online NHLBI workshops. Mentors. Dr. Nowalk has designed a
complementary mentorship team at UChicago. His primary mentor is Dr. Valerie Press (primary sponsor) and
she carries a K24 mentoring award for respiratory topics in patient oriented research. Dr. Nowalk and Dr. Press
have met weekly since 2022. Dr. Esra Tasali (co-sponsor) is a trialist studying the cardiometabolic outcomes of
sleep disruption and Dr. Phillip LoSavio (co-sponsor) is an international expert in sleep surgery. Dr. LoSavio is
the principal investigator for the clinical trial Dr. Nowalk is working under for this proposal. Aims. Using a
prospective, single-group trial of patients with OSA before and after HNS surgery, Dr. Nowalk will determine the
impact of HNS therapy on: glucose metabolism using continuous glucometers and fasting serum studies (Aim
1) and cardiovascular health using an ambulatory blood pressure monitor, serum studies, and a wearable activity
monitor (Aim 2). Deliverables. During this one-year award, Dr. Nowalk's aims will lead to 2-3 first-author
publications and presentation at 2 international conferences. The results will serve as data for his K23
application, which will focus on a trial examining the cardiometabolic profiles of endotypes in OSA.

Public health relevance
PROJECT NARRATIVE Obstructive sleep apnea (OSA) is a highly prevalent sleep disorder in the general population and an independent risk factor for cardiometabolic disease, but first-line treatment by positive airway pressure (PAP) is limited by patient tolerance. Hypoglossal nerve stimulation (HNS) therapy is a surgical alternative to PAP that is rapidly being adopted, but our understanding of the cardiometabolic outcomes of treating OSA by this therapy is unknown. Working within a prospective, single-group trial, this proposal will perform cardiometabolic profiles of patients before and after HNS therapy to potentially inform the care of millions of patients suffering from OSA.